Mechanisms and Applications of RNA-mediated Enzymes in Translation and Immunity

PROJECT SUMMARY
Description: RNA-guided, or ribonucleoprotein particle (RNP), enzymes comprise an emerging class of
molecules that function in a wide range of biological pathways. Unlike most of the protein-based enzymes,
RNP enzymes rely on the guide RNA to secure the substrates and on the partner proteins to catalyze the
chemical reactions. The RNA-guided targeting mechanism has created unprecedented opportunities in
genome manipulation, gene regulation and nucleic acid detection. Research in the Li laboratory employs
structural biology and complementary methods to uncover the theoretical basis for their biological function and
effective use as research, diagnostic and therapeutic tools. In the proposed funding period, the Li laboratory
will tackle the mechanisms of the RNP enzymes to enable their applications. These include the methylation-
sensitive Clustered, Regularly Interspaced, Short Palindromic Repeats (CRISPR)-Cas9, the multi-functional
Type III CRISPR effectors and their associated signaling processes, and the small nucleolar RNPs (snoRNPs)
responsible for chemical modifications of ribosomal RNA. Though unrelated in enzyme composition or
biological pathway, these RNP enzymes are governed by a similar set of physicochemical principles and share
the great potential in therapeutic and diagnostic innovations by reprogramming the chemistry of cellular nucleic
acids. The proposed research will assess the feasibility of engineering and applying the epigenetic DNA-
specific Cas9, the utility of rapid virus detection with the CRISPR Type III effectors, and the possibility of
tunning cellular functions through chemical modifications of RNA. The Li laboratory has assembled a team of
scientists with complementary expertise in microbiology, mammalian genome biology, yeast genetics, single
molecule biophysics, virology, virus detection, X-ray crystallography, and high-throughput cryogenic electron
microscopy to maximize the impact while mitigating the risks of the research. The goal of this transformative
proposal is to demonstrate and enable the applicability of the RNA-mediated enzymes in a wide range of
biomedical fields.

Public health relevance
PROJECT NARRATIVE Molecular principles of four RNA-mediated machineries including CRISPR-Cas enzymes from bacteria and snoRNPs from yeast will be studied towards construction and testing of innovative anti-cancer therapeutic, genome manipulation and virus detection tools.